Standing Strong in Tribal Communities: Assessing Elder Falls Disparity

Program Director/Principal Investigator (Last, First, Middle): Shah, Vallabh O and Herman Carla
Native elders are essential to preserving the culture and history of tribal communities, but fall-related injuries can
jeopardize their ability to age in place. The Zuni Pueblo is geographically isolated with limited access to
rehabilitative and supportive services. Home health physical therapy services are unavailable at the Pueblo.
Therefore, Zuni elders must choose between leaving their community and social network for rehabilitative care
or remain in the community with unmet needs, and increased risk of not regaining their prior level of function.
We propose to culturally tailor the traditional Physical Therapy delivered Otago Exercise Program (OEP), to
evaluate its effectiveness in reducing falls risk and to empower elders and their families to engage in preventing
falls in their community. Native Zuni CHRs will deliver OEP using novel consultation and telehealth with a
Physical Therapist. The CHRs offer important advantage of speaking “Shiwi” (Zuni tribal language) and
understanding Zuni traditions, family structures, and elders’ preferences for receiving health information. Our
overall objective is to compare the effectiveness of a CHR-delivered, culturally-adapted OEP fall prevention
program to the standard of care education-based fall risk management.
Our disparity driven aims are: Aim 1: Foster a sustainable multi-directional, participatory collaboration between
the Zuni’s tribal leadership, stakeholders, Zuni Indian Health Services, and University of New Mexico Health
Sciences Center to enhance fall prevention training, education, and research; Aim 2: To culturally adapt the
evidence-based OEP for use with the Zuni elder population. Approach: We will train CHRs to utilize the CDC
STEADI toolkit for fall risk screening and education and CHRs will culturally adapt the education and OEP with
input from Zuni elders; Aim 3: To compare the effectiveness of the adapted OEP to an education-based fall risk
management usual care program in improving strength and balance and reducing falls risk. Approach: Screen
400 Zuni elders, aged 65yrs and older, to identify 200 elders with elevated fall risk. Randomize 200 Zuni elders
at risk for falls into a 6-month OEP intervention versus education-based control; and Aim 4: To compare the
effectiveness of the adapted OEP to an education-based fall risk management program in improving overall
health status, self-management of daily activities, and social engagement. Approach: We will administer SF-12
Health Survey and Short Form PROMIS measures Self-Efficacy for Managing Daily Activities and Ability to
Participate in Social Roles and Activities to all randomized participants, at baseline and 6 months, and during
the final follow up visit at 12 months.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Shah, Vallabh O and Herman Carla Falls and fall-related injuries are major health risks for our disparity population of American Indian elders. Our pilot study showed 52% of Zuni elders reporting a fall during the past year, which is significantly higher than the US national average of one out of three adults 65+. In partnership with Zuni Pueblo leadership and community stake holders, we seek to study the feasibility of implementing Community Health Representative (CHR) delivered fall risk screening and evidence-based Otago Exercise Program to address lack of access to home- delivered physical therapy and health disparity, as well as empower elders to address fall risk, avert injury, and preserve aging in place within their community.